RNA-Binding Proteins and RNA-Dependent Proteins - An Emerging Role for RNAs in Plasmodium Biology

Abstract
Nearly half of the world’s population lives in countries where malaria is endemic. Plasmodium falciparum, the causative
agent of the most severe form of human malaria, is responsible for 95% of malaria deaths worldwide. The project’s main
goals are to identify RNA-binding proteins (RBPs) and RNA-dependent proteins (RDPs) in the pathogen; elucidate their
importance in parasite development; and finally identify novel pathways that can be targeted to kill the parasite.
Ribonucleoprotein complexes are composed of RNA, RBPs, and RDPs and have been shown to play fundamental roles in
RNA regulation in eukaryotic organisms. However, in the human malaria parasite, P. falciparum, identification and
characterization of these proteins are particularly limited. Our lab has used several approaches including an unbiased
proteome-wide approach, called R-DeeP, a novel method based on sucrose density gradient ultracentrifugation, to
successfully identify not only RBPs but also RDPs in the asexual stages of the P. falciparum life cycle. Using quantitative
analysis by mass spectrometry as well as a combination of computational and molecular approaches, we identified over
800 RDPs, including 500+ proteins not yet associated with RNA. We also reconstruct Plasmodium multiprotein complexes
based on their co-segregation and their RNA-dependence. One RDP candidate was functionally characterized and
validated as interacting in complex with various Plasmodium non-coding transcripts, including var genes and several ap2
transcription factors. Overall, our novel genome-wide proteomic and molecular approaches provided the first snapshot
of the Plasmodium protein-protein interaction networks in the presence and absence of RNA in the asexual cycle of the
parasite. No data were however acquired for parasite sexual differentiation, a stage essential for the transmission of the
pathogen to the mosquito vector. We therefore now propose to use our novel R-DeeP methodology to not only identify
and reconstruct Plasmodium multiprotein complexes based on their RNA-dependence during the parasite sexual
differentiation but also validate their potential as new therapeutic targets. We have therefore designed the following two
specific aims. In AIM 1, we will adapt and expend our unbiased proteome-wide approach to identify RDPs from early and
late gametocytes. Our data will also be used to determine RNA dependent multiprotein complexes that are specific to
these parasite sexual stages. In AIM 2, we will use a combination of CRISPR-Cas9 genome editing tools as well as functional
genomics approaches to validate the role of RDPs candidates that are involved in sexual differentiation. The results of this
work will transform our understanding of the role of RNA-dependent protein complexes (RDPCs) in the parasite biology
and identify novel intervention strategies that may interrupt the development of malaria parasites.

Public health relevance
Project narrative The Apicomplexa is a phylum of diverse obligate intracellular parasites infecting humans including Plasmodium, the causative agent of malaria. In this application, we aim to decipher the role of RNA-binding proteins (RBPs) and RNA- dependent protein (RDPs) in the parasite biology and validate their potential as novel targets for antiparasitic strategies.